The Role of Food Insecurity and Sensitization in Excess Weight Gain in Adolescents from Low to Moderate Income Households

Abstract: The etiology of obesity is complex and is driven by different factors in different populations,
including across developmental stages, in different racial and ethnic communities, and at different levels of
socioeconomic status (SES). It is important to identify the factors that promote excess energy intake in the
highest risk populations to develop evidence-based, effective obesity prevention and treatment strategies.
Over the past decade, it has become apparent that studying behavioral phenotypes that predict overweight,
obesity, and weight change across the lifespan is critical for developing individualized intervention strategies
with a high degree of efficacy and effectiveness. One novel phenotype that has been identified and
characterized is sensitization of the relative reinforcing value (RRV) of food. This is defined as an increase in
the RRV of a food after repeated, daily consumption of high energy density (HED) food for two weeks. In
adults, sensitization is positively associated with BMI and prospectively predicts weight gain over time. The
cross-sectional relationship between zBMI and sensitization has been replicated in a cohort of adolescents
enrolled in the UBSNAK study and recent data have shown that, as in adults, sensitization prospectively
predicts zBMI change in adolescents. It is also known, from preliminary work, that the relationship between
food insecurity and zBMI is associated with other individual, behavioral, and environmental factors, such as
delay discounting, perceived stress, and self-efficacy for healthy eating. The goals of the proposed study are
1) to investigate the relationship between food insecurity and sensitization 2) to determine the role of
sensitization in determining zBMI and zBMI change in a population of moderate to low-income adolescents
and 3) to determine how adolescent food insecurity interacts with household food insecurity to moderate the
relationship between sensitization and zBMI change. The first aim will test the hypothesis that food insecurity
is related to sensitization and that this relationship is mediated by individual, behavioral, and environmental
factors. The second aim will test the hypothesis that household food insecurity moderates the relationship
between sensitization and zBMI change over time in adolescents. The third aim will test the hypothesis that
adolescent food insecurity interacts with household food insecurity to moderate the relationship between
sensitization and zBMI change and that one factor that impacts this relationship is adolescent eating
autonomy. When taken together, this study will help to identify and characterize novel intervention targets in a
population of adolescents at higher risk for overweight and obesity.

Public health relevance
Project Narrative: Children from food insecure households are at higher risk for overweight, obesity, and other chronic disease and more research is needed to identify and characterize individual, behavioral, and environmental factors that underlie these relationships. This study will examine a novel behavioral phenotype, sensitization to repeated intake of snack food, and its relationship with food insecurity, body weight and weight change over time in a cohort of adolescents from moderate to low income families. We will also examine the impact of family dynamics of food insecurity on the relationship between sensitization and weight change over time.